Molecular mechanistic studies of long “noncoding” RNAs in mammalian cell differentiation

Project Summary/Abstract
The goal of this application is to obtain funding for purchasing the Jess System from the
ProteinSimple for automatic and quantitative protein analysis. The Jess System will offer us high
sensitivity, high reproducibility, accurate protein quantification, and high throughput automated fast
protein analysis. These technical capabilities will significantly improve our research programs and
enhance the Rigor and Reproducibility of our research outlined in our parental R01 award.

Public health relevance
PROJECT NARRATIVE The goal of this application is to obtain funding for purchasing the Jess System from the ProteinSimple for automatic and quantitative protein analysis. We believe this new equipment will greatly facilitate and enhance our research programs outlined in our parental R01 award “Molecular mechanistic studies of long “noncoding” RNAs in mammalian cell differentiation”